Multidimensional Quantitative Imaging Core

PROJECT SUMMARY/ABSTRACT
The Multidimensional Quantitative Imaging Core will provide quantitative image, genomic and statistical
analysis for microscopy and sequencing projects generated by the Center's research investigators.
Formerly, the Core operated as a Computational Biology Core and focused only on providing expertise for
genomic and statistical analysis for the P50 investigators' projects. We have expanded the scope of the
Core to include image analysis since many of the P50 investigators' projects will examine cellular and
subcellular morphological changes that accompany changes in differentiation, maturation and cell lineage
specification. One of the goals of the core is to apply new advances in deep learning to image recognition
of cellular structures. Since applying deep learning techniques requires significant computational resources
as well as expertise in image acquisition and analysis, the Core facility is better suited and equipped to
handle these types of analyses than individual investigators or teams. The Core is partnering with UCSF's
Center of Cellular Construction to develop general deep learning algorithms for image analysis of cell
biology. The Core will also integrate “omics” data with imaging data by aiding in the development of de
novo mapping analyses to integrate the disparate datasets. Finally, the Core will participate in training and
educating P50 students, interns and fellows in the best practices of bioinformatics and image analysis.

Public health relevance
PROJECT NARRATIVE The Multidimensional Quantitative Imaging Core will provide quantitative image, genomic and statistical analysis for microscopy and sequencing projects generated by the Center's research investigators. The services the Core provides will aid investigators in their research into normal and abnormal endometrial cell function, oocyte maturation and placental differentiation and will contribute to the knowledge necessary for creative medical discoveries to improve human reproductive health.